HOMOCYSTEINE IN CEREBRAL AND PERIPHERAL VASCULAR DISEASE

This study examines the relationship between plasma levels of homocysteine and the existence, the extent of, and the rate of progression of peripheral and cerebral vascular disease.